H3 histone oxidation is a new posttranslational modification linking heavy metal-induced metabolic changes and oncegenic epigenetic reprogramming

SUMMARY
Transcription stability enforces cellular identity and is tightly controlled by restrictions imposed on
both transcription factor function and target gene accessibility. Progression of cancer to
metastasis and multi-drug resistance requires fluid transcriptional programs that can explore
different genomic landscapes to enable clonal diversification and the origination of aggressive
and treatment resistant phenotypes. In this application, we explore the recent discovery that an
increase in the production of mitochondrial reactive oxygen species (mtROS), induced by heavy
metal contaminants (such as arsenic, lead and cadmium) promotes histone H3.1 oxidation,
eviction from nucleosomes and replacement by the oxidation-resistant variant H3.3. Oxidation-
induced H3 variant replacement opens silenced portions of chromatin thereby licensing epithelial
to mesenchymal transition (EMT) of ER+/PR+ breast cancer cells leading to the origination of
aggressive, therapy-resistant and metastatic phenotypes. Protecting H3.1 from oxidation (using
pharmacologic compounds) seem to block metal-induced EMT thereby improving chemotherapy
outcomes of metal-transformed xenograft tumors treated in mice. The fact that suppressing
nuclear ROS opposes metal-induced EMT also suggests that there is a key pathway for
transformation downstream of the many targets of heavy metals in cells that can be explored for
therapeutic gain. We suggest that metal-induced H3.1 oxidation by mitochondrial ROS is a new
regulatory link between metal-induced changes to the cancer cell metabolism and chromatin
remodeling controlling gene expression programs that enable breast cancer progression and drug
resistance acquisition. Hence, we believe that developing pharmacologic solutions to target this
pathway in the short term may represent a significant step forward towards mitigating grave
consequences of environmental health injustice disproportionally affecting low income breast
cancer patients.

Public health relevance
NARRATIVE Heavy metal pollution by arsenic (iAs), Cadmium (Cd) and lead (Pb) disproportionally affects low income and historically underappreciated communities nationally and internationally. We found that these metals alone and in combination, at doses much lower than the World Health Organization (WHO) recommended limits, promote an increase in the generation of reactive oxygen species by ER+/PR+ breast cancer cell mitochondria leading to chromatin oxidative remodeling in the nucleus and the progression of the disease to multi-drug resistant metastasis. This project proposes the development of new and FDA-approved pharmacologic nucleus- and mitochondria-targeted antioxidants as chromatin protective agents to spare H3.1 from oxidation and prevent heavy metal-induced worsening of breast cancer for patients impacted by socioeconomic and environmental health disparities.